Estimation and inference in directed acyclic graphical models for biological networks

Summary
As biotechnology advances, biomedical investigations have become more complex due to high-throughput and
high-dimensional data collected at a genomic scale. Of paramount importance is unraveling the regulatory roles
of genetic variants on genes and gene-to-gene regulatory relationships. On this ground, biomedical researchers
can identify causal Single-Nucleotide Polymorphisms (SNPs) and genes for complex traits and neurodegenerative
diseases such as Alzheimer's disease (AD) to develop treatment strategies. Given the urgent need to under-
stand the progression and etiology of these diseases, particularly AD, the PIs propose to develop statistical and
computational tools for accurate estimation and inference of gene regulatory networks, with a focus on AD and
other complex traits.
The project consists of two major components: estimation and inference of gene regulatory networks with
SNPs as instrumental variables (IVs). The main thrust will be on causal network reconstruction and inference
with IVs as interventions in the possible presence of invalid IVs and hidden confounders, with particular effort
on high-dimensional data, in which the number of variables may exceed the sample size. Concerning causal
network reconstruction, the project will develop novel methods of reconstructing gene regulatory networks as
directed acyclic graphs describing casual relationships among the SNPs (interventions), genes, and traits such
as AD. The project will develop high-dimensional inferential tools based on modiﬁed likelihood ratio tests and a
data perturbation scheme to account for the uncertainty involved in a discovery process. Moreover, it will focus
on hypothesis testing on (1) the directionality and strength of multiple (linear/nonlinear) causal relations and (2)
the presence of a pathway of causal relations. Computationally, the project will develop innovative methods and
algorithms for large-scale problems. For application, based on the reconstructed gene regulatory networks, we
will ﬁrst identify causal genes for AD and AD's risk factors, such as lipids, then infer which of the risk factors are
(putatively) causal to AD.

Public health relevance
Project Narrative The proposed project will address fundamental issues for reconstruction and inference of high-dimensional causal networks, then apply the developed new methodology to the elucidation of causal genetic variants, genes, and risk factors for Alzheimer's disease (AD) with potential applications to other common illnesses. Thus it will facilitate their prevention, early diagnosis, and therapeutic development.